Role of Long Intergenic Noncoding RNA in UVB-induced Apoptosis and Skin Cancer

This request proposal is for an Administrative Supplement to (ES024471) “Role of Long Intergenic Noncoding RNA in UVB-induced Apoptosis and Skin Cancer” to provide support for a summer research experience for an undergraduate student. This proposed research project will promote the candidate's research skills and knowledge in environmental health sciences and toxicology. In this proposal, a detailed research and mentoring plan are described for the summer student.

Public health relevance
RNAs that lack protein coding function are referred to as noncoding RNAs and of these the long noncoding RNAs (lncRNAs) represent the majority with over 10,000 different lncRNAs reported in the human genome. Only a few lncRNAs have been studied to date, but emerging evidence suggests they have a key role in regulating gene expression and are associated with human diseases such as cancer, Alzheimer’s and heart disease; it is critical to define the function of lncRNAs in disease because such an understanding could allow for development of new prognostic markers, biomarkers for early cancer detection and molecular targets for therapy. Given that the etiology of most chronic diseases involves interactions with the environment, it is vital to understand if environmental factors impact the expression, activity and function of lncRNAs to contribute to disease as such an understanding could provide opportunities for disease prevention.